DEVELOPMENT OF CANCER CONTROL EPIDEMIOLOGIC METHODS

The development of the methods of cancer control epidemiology has focused on these areas: 1) studies in causal and preventive inference, 2) studies in interactions, 3) the analysis of epidemiologic reasoning, 4) the ethics of prevention, and 5) design of cancer control research studies. Criteria for causal and preventive inference have been improved. Previous criteria fall into two categories: those dependent upon the specific form of the hypothesis and those independent of the form of the hypothesis. Two general criteria replace all existing criteria: predictability and testability. Research underway includes 1) application of general criteria of epidemiologic inference to determine the status of hypotheses that dietary alcohol causes breast cancer, that dietary fat causes cancers, and that dietary fiber prevents colon cancer, 2) predicting magnitudes of effects from the sufficient component causes model and examining the role of magnitude of association in making inferences, 3) application of a new causal theory (epigenesis theory) to the evaluation of causal and preventive interactions, 4) application of a new method of epidemiologic reasoning (mega-analysis) to the use of case-control methods for screening; the use of negative results in causal inference; the debate regarding the use of p-values, confidence limits, and p-value functions; the role of complexity of causal inference; and the links between scientific, technologic and ethical reasoning, 5) a critical study of the ethics of epidemiology in advising for or against preventive interventions, and 6) defining criteria and issues of phase IV (defined population) studies.